Local protein synthesis in tau pathology neurodegeneration

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease is a progressive, age-related, degenerative brain disease. The most notable symptom
is a significant cognitive impairment accompanying a substantial loss of dendritic spines and, eventually, neurons
themselves. Since these end-stages are mostly irreversible, it is critical to identify appropriate molecular targets
for intervention before the synaptic dysfunction and neuronal loss become permanent. Brains with Alzheimer's
disease display the presence of increased protein accumulations, such as intracellular tau inclusions
(neurofibrillary tangles) and extracellular beta-amyloid deposits (senile plaques). However, alterations in synaptic
structure, function, and plasticity appear before these pathologies arise in various Alzheimer's disease models,
highlighting the pathological significance of early-stage synaptic alterations, potentially driven by Alzheimer's
disease-associated proteins, as a proximal event in Alzheimer's disease etiology.
Importantly, it is now widely accepted that local protein synthesis plays essential roles in neurons and, in
particular, that key components of protein synthesis subserving synapses and synaptic plasticity take place in
dendrites, in association with dendritic spines, the cellular site of synaptic plasticity. These observations lead us
to hypothesize that pathogenic forms of tau specifically interfere with dendritic protein synthesis and that this
effect contributes to the pathologic features seen in Alzheimer's disease. We propose to test this hypothesis by
taking advantage of tau pathology model mice and a novel suite of genetically encodable molecular tools
implementable in these animals to address dendritic protein synthesis in the hippocampus.
Successful completion of this project will enrich our understanding of how tau pathology leads to early
synaptic dysfunction in Alzheimer's disease. Ultimately, these studies will provide molecular insights into target
molecules for intervention before the irreversible loss of synapses and neurons in Alzheimer's disease and
related dementia.

Public health relevance
PROJECT NARRATIVE The proposed research aims to understand how tau pathology alters protein biogenesis in neuronal compartments. Thus, this proposal is relevant to the part of the NIH's mission that pertains to understanding the pathogenesis of Alzheimer's disease and related dementia and discovering molecular targets for therapeutic intervention.